Dopaminergic Regulation of KNDy Neurons: Implications for GnRH Pulses and PCOS

ABSTRACT
KNDy neurons in the arcuate nucleus (ARC) control GnRH pulsatility through the interplay of neurokinin B (NKB)
and dynorphin, creating kisspeptin pulses that directly stimulate GnRH neurons. Disruptions in this system can
lead to various reproductive disorders, from hypothalamic amenorrhea to polycystic ovary syndrome (PCOS).
Our recent work has shown that peripherally restricted kappa opioid receptor agonists (PRKAs) can activate
dynorphin's receptor (KOR) in the mediobasal hypothalamus, decreasing LH release and restoring reproductive
markers in a PCOS mouse model. Intriguingly, this effect persists even without KOR in Kiss1 neurons,
suggesting an upstream target. We aim to identify and characterize the neuronal population that is peripherally
accessible, responsive to dynorphin, and capable of modifying KNDy neuron activity. Tuberoinfundibular
dopaminergic (TIDA) neurons emerge as prime candidates, exhibiting oscillatory patterns similar to KNDy
neurons and correlating with prolactin and LH pulses. Moreover, our preliminary data has identified that KNDy
neurons are uniquely enriched with dopamine receptor 2 (Drd2) in the ARC, and dopamine levels are reduced
in PCOS models. Our overarching hypothesis posits that TIDA and KNDy neurons form a major oscillatory
network controlling GnRH release, with decreased dopamine tone in PCOS leading to KNDy neuron
hyperactivation, reversible by PRKAs. We will investigate this through three aims: 1) examining KNDy activity in
normal and PCOS-like conditions and their PRKA response, 2) characterizing dopamine's role in KNDy neuron
activity, and 3) elucidating TIDA neurons' role in KNDy neuron control under various conditions. This project
promises to unveil novel mechanisms in reproductive neuroendocrinology and may lead to innovative PCOS
treatments.

Public health relevance
NARRATIVE This research project aims to elucidate the complex neuroendocrine mechanisms underlying GnRH pulse generation, with a focus on the interplay between KNDy neurons and tuberoinfundibular dopamine (TIDA) neurons in the context of polycystic ovary syndrome (PCOS). Using cutting-edge techniques including fiber photometry, CRISPR/Cas9 gene editing, and chemogenetics, we will investigate the dopaminergic regulation of KNDy neurons and the potential of peripherally restricted kappa opioid receptor agonists (PRKAs) as a novel treatment for PCOS. Our findings could improve our understanding of reproductive neuroendocrinology, potentially leading to new diagnostic markers and non-hormonal treatment strategies for PCOS and other reproductive disorders, thereby significantly advancing Women's Health.